Priming the Rehabilitation Engine: Aerobic Exercise as the Fuel to Spark Behavioral Improvements in Stroke

Stroke is a leading cause of disability in the United States and poses a significant burden to Veterans. The
effectiveness of current intervention approaches is limited and many individuals following stroke live with
persistent functional, cognitive and psychological impairments that significantly reduce long-term quality of life.
The prevalence of post-stroke disability coupled with reduced stroke mortality rates reflects an increasing need
to develop effective rehabilitation strategies aimed at reducing disability and improving quality of life for Veteran
stroke survivors. Aerobic exercise (AEx) promotes numerous functional, cognitive, and psychological benefits.
Additionally, AEx may enhance neuroplasticity through increases in circulating brain-derived neurotrophic factor
(BDNF) and corticomotor excitability (CME). Emerging evidence also supports the use of AEx as a priming tool
to enhance motor outcomes following targeted rehabilitation. Our conceptual framework involves priming with
AEx prior to targeted motor rehabilitation to enhance the ‘neuroplastic environment” and make the brain more
amenable to adaptation, thereby enhancing response to rehabilitation. Specifically, we propose to pair AEx with
an upper extremity virtual reality rehabilitation game called Duck Duck Punch (DDP), developed by our team
(Co-mentor: Woodbury) as the platform for examining the adjunctive potential of AEx. Therefore the primary
aim of this proposal is to evaluate the priming effects of AEx on a motor rehabilitation intervention (i.e.
DDP) for chronic stroke survivors. This will be accomplished by examining a cohort of stroke survivors who
will be randomly assigned to receive 8 weeks (3 sessions/week) of DDP preceded by either 15 minutes of AEx
(AEx+DDP) or a stretching control (CON+DDP). Assessment of physical function before and after the
intervention will provide insight into the ability of AEx to enhance the response to motor rehabilitation. The
secondary aim of this proposal is to gain insight into the mechanisms that underlie the priming effects of AEx
through assessment of circulating BDNF and CME. Additionally, since stroke survivors often experience
cognitive and psychological impairments we will also explore the influence of cognitive and psychological
function on response to AEx+DDP. A potentially exciting possibility is that AEx facilitates an enhanced
neuroplastic environment, which fosters improved function in a variety of aspects of stroke recovery including
physical, cognitive, and psychological function. This proposal will be supported by the infrastructure and
resources provided by the South Carolina Research Center for Recovery from Stroke (NIH P20 GM109040).
Furthermore, the combination of the Ralph H. Johnson VA Medical Center and its affiliated academic institution,
Medical University of South Carolina is uniquely positioned to fill the aforementioned gap in understanding for
several reasons: 1) Charleston, South Carolina has one of the highest rates of stroke in the nation, and 2) in the
last 5 years we have received over $23 million in research funds to support rehabilitation research in stroke
recovery. During the award period, the applicant will capitalize on the opportunity to utilize these resources to
develop the requisite skills and understanding of neurobiological data acquisition, analysis, and interpretation
through direct hands-on training from local renowned experts. The overall goal of this CDA-2 application is
to expose the candidate to a rich local environment for stroke recovery research, providing the
foundation for his development into an independent VA researcher studying the effects of exercise-
based interventions, alone or as adjuvants, for the treatment of Veterans. To accomplish this goal, the
proposed training plan will enhance the candidate’s understanding of the neurobiological effects of AEx and the
design and delivery of neurorehabilitation trials. The data generated will inform the development of additional
AEx-based interventions aimed at improving function and quality of life for individuals following stroke and
perhaps other neurological or neuropsychiatric conditions.

Public health relevance
Stroke is a leading cause of disability in the U.S. and many Veteran stroke survivors live with severe disability. Despite recent advances in rehabilitation treatments many stroke survivors have persistent physical and mental difficulties such as reduced physical and cognitive function and depression. Developing innovative treatments that address these problems is necessary to improve long-term outcomes for stroke survivors. Aerobic exercise (AEx) can improve physical and cognitive function, and reduce depression. Additionally, AEx may enhance physical rehabilitation by making the brain more receptive to, and consequently improving the response to an intervention. Therefore, combining AEx with physical rehabilitation has the potential to improve multiple aspects of stroke recovery. This study will examine the effect of combining AEx with physical rehabilitation on physical and mental function in stroke survivors. By gaining a better understanding of the effects of this combined intervention we aim to advance the rehabilitative care of Veteran stroke survivors.